NONISOTOPIC IMMUNOASSAYS FOR CYCLIC NUCLEOTIDES

The overall objectives of the Phase II effort are to develop additional antibodies against cyclic nucleotides (including cCMP) to compliment the antibodies generated during the fulfillment of prototype non-isotopic immunoassays for the measurement of cyclic nucleotides, and to complete the development of the assays in collaboration with BAbCO's Phase III partner (Boehringer Mannheim).